Identification of School-age Eye conditions Evaluation (ISEE)

Significant vision problems (SVP), such as significant uncorrected refractive error, amblyopia, and
strabismus are common in school-age children and may impede learning. Vision screening, a key public health
tool to identify school-age children at risk for SVP, is mandated in 41 states, however it is not known which
currently used screening test(s) effectively identify at-risk school-age children. Timely, appropriate eye care for
children who are identified through screenings can improve quality of life, facilitate learning, and decrease the
burden of lifelong vision problems, and its attendant economic costs. Currently there is great variation in state
vision screening requirements and in approaches adopted among organizations involved in screenings. There
is a need for evidence-based school-age vision screening guidelines and policies, however this will require
much more robust data on the effectiveness of screening tests than are currently available. Effective screening
tests must have high sensitivity and specificity to accurately identify those at risk for SVP while avoiding undue
and costly over-referrals. Lay and nurse screeners also must be able to successfully administer the screening
tests to children, interpret findings and make appropriate referrals. Limitations of prior screening studies in
school-age children include: 1) examining only those referred, leaving the percentage with missed SVP
unknown; 2) evaluating only 1-2 instruments without comparing available screening approaches concurrently;
3) including a wide age range, without subgroup analysis in the school-age population; 4) small sample size
with limited range of SVP included; 4) not evaluating sensitivity to detect each type of SVP; 5) using definitions
of targeted SVP that vary and may miss visually significant refractive error in school-age children; 6) not
including newer technologies. Thus, valid full-scale, side-by-side comparisons between alternative screening
tests are vital. There is also a paucity of information on how SVP affect quality of life in school-age children.
Considering disparities in access to eye care after vision screening referral, greater understanding of the
facilitators as well as barriers for obtaining needed care after screening referral is also urgently needed.
This proposal aims to show the feasibility of a full-scale, multi-center, multidisciplinary study to compare the
effectiveness of using traditional (visual acuity and stereoacuity) and technology-based vision screening tests
for identification of school-age children at risk for SVP and in need of an eye exam. Before conducting the full-
scale study, we must show the feasibility of enrolling children at each site, completing vision screening testing,
and collecting eye exam results. We will also refine study procedures (e.g. training, certification, testing, data
collection, data management, and analysis) and develop a Manual of Procedures and Protocol for the planned,
full-scale UG1 study. We also will seek input from key organizations involved in conducting or setting
standards for children’s vision screening to ensure that crucial questions, including equitable access to care,
will be addressed in the full-scale study. The findings will help inform future screening guidelines and policies.

Public health relevance
Vision screening, a key public health tool to identify children at risk for vision problems (significant uncorrected refractive error, amblyopia, and strabismus) is currently mandated in 41 states; however, it is not known which currently used screening test(s) effectively identify at-risk school-age children in need of further eye care. Development of evidence-based school-age vision screening guidelines and policies requires much stronger data on the effectiveness of screening tests than are currently available. This planning grant helps lay the foundation for a future UG1 to perform a full-scale study with side-by-side comparisons between alternative screening tests to determine the best screening test(s) for identification of school-age children at risk for significant vision problems that are common in school-age children and may impede learning.